Centrosome instability as a mechanism to promote localized prostate cancer

PROJECT SUMMARY/ABSTRACT
There is a fundamental gap in our knowledge to explain the origin of prostate cancer (PCa). Unlike many
cancers, PCa lacks signature mutations in key oncogenes and tumor-suppressor genes and, instead,
displays large-scale genomic instability. We propose to study subcellular organelle instability as a
mechanism that results in genomic instability in epithelial cells of the prostate gland. Specifically, we focus
on centrosomes, tiny cytoplasmic organelles that dramatically influence genome integrity. Centrosomes can
become subcellular pathognomonic structures when they are amplified, as is the case in many different
cancers, causing mitotic errors, genomic instability and inducing tumorigenesis in mouse models.
Likewise, centrosome loss causes mitotic errors and genomic instability identical to centrosome
amplification, but has not been reported in cancer. We discovered recently that human prostate
adenocarcinoma lack centrosomes, providing a novel mechanistic explanation for genomic instability in
PCa. Our long-term goal is to discover the abnormal changes that underlie prostate tumorigenesis,
malignancy and recurrence, and to improve PCa diagnosis and treatment strategies. The objective of this
application is to determine the contribution of centrosome loss in driving genomic instability resulting in
PCa and to determine the molecular mechanistic basis for centrosome disappearance. Drawn from our
preliminary data, our central hypothesis is that hypoxia is a key physiologically-relevant determinant of
centrosome loss in the prostate which, in turn, stimulates genomic instability and tumorigenesis. The
rationale for the proposed research is to address the provocative question of how cancer-specific changes in
subcellular pathognomonic structures (specifically, centrosome loss) transpire and contribute to
carcinogenesis. This hypothesis will be tested in three specific aims: 1) Determine whether centrosome loss
is triggered by hypoxia in prostate cells and tumors; 2) Determine whether centrosome loss drives
genomic instability in normal prostate epithelial cells and promotes tumorigenesis; and 3) Determine if
centrosome loss is characteristic of high-grade prostatic intraepithelial neoplasia (PIN, carcinoma in situ).
The approach is innovative because it investigates a novel mechanism of subcellular organelle instability
during prostate tumorigenesis: specifically, that hypoxia and centrosome biogenesis are mechanistically
coupled as drivers of genomic instability in prostate tumor formation. The proposed research is significant
because it tests a new concept that the loss of a critical subcellular organelle is responsible for PCa
genomic instability, which is both a hallmark and agent of prostate tumor evolution. If we are correct,
centrosome loss will be a tangible event early in the genesis of human prostate cancer, providing new
early detection and treatment strategies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the work will dissect a mechanism that can promote genomic instability in normal prostate epithelial cells. Since genomic instability is both an oncogenic hallmark and probable tumorigenic driver of prostate cancer, this project is relevant to the NIH mission because it will uncover new molecular events to aid therapy decisions to distinguish indolent from aggressive disease and aid precision oncology strategies.